Core B: PDX/Biospecimen Core

The PDX/Biospecimen Core B provides part of the infrastructure support for the P01 Projects. It
has been designed to meet the needs of these projects and serve as a stand-alone resource for
collaborative efforts. The Core B will provide a well-organized and standardized system of
specimen collection, storage, distribution and related clinical/research information
dissemination. There will be consistency and quality assurance in the pathological analysis of
tissue specimens. Specimens from our repository, our LuCaP prostate cancer PDXs and clinical
specimens, particularly those from our rapid autopsy program (e.g. prostate cancer bone
metastases) have been and will continue to be distributed to other prostate cancer investigators
on a national and international basis. The Core B Specific Aims are: 1) Maintain and Distribute
Patient-Derived Prostate Cancer Xenografts, 2) Collect and Distribute Clinical Biopecimens (i.e.
tissues, including those from surgery and the rapid autopsy program, serum, plasma and urine),
processing, quality control, storage, distribution and database entry, 3) Establish and Maintain
Specimen Quality and Core B Service Efficiency Programs, 4) Provide Specialized Pathology
and Laboratory Services, including production of tissue microarrays, interpretation of
immunohistology by urologic pathologists, production of specimen derivatives and perform PSA
immunoassays for research, 5) Administrative Program to obtain samples from minorities,
prioritize the distribution of specimens, ensure patient confidentiality and compliance with IRB
requirements, and continually improve quality control measures.

Public health relevance
The performance of translational research mandates that investigators have ready access to well- characterized clinically and biologically relevant models, and well documented clinical specimens. The PDX/Biospecimen Core B directors have decades of experience in recognizing these needs and providing such services not only to local investigators but to those who request specimens on a world-wide basis, and these interactions will continue.